The sex-specific role of degradation-specific protein polyubiquitination in fear memory formation

This attachment is not required by FOA PA-21-071; this placeholder is just
to resolve system-to-system solution errors.

Public health relevance
This attachment is not required by FOA PA-21-071; this placeholder is just to resolve system-to-system solution errors.